DEVELOPMENTAL AND NEONATAL BIOLOGY TRAINING PROGRAM

The aim of the Training Program in Developmental and Neonatal Biology is to provide educational opportunities for young people to achieve excellence in clinical newborn medicine, scholarly basic science and clinical research, and medical education. The Program is designed to encourage the cross-fertilization of ideas that will enrich the ideas of both the basic- and the clinically-oriented scientist. For those trainees interested in clinical training, the Program offers intensive clinical experiences with newborns, including the opportunity for clinical investigation, as well as the opportunity for advanced study in developmental biology, especially at the cellular and molecular level. For those trainees interested in the basic sciences, the Program offers exposure to clinical problems that stimulate curiosity in human development and enhance the translation of bench research discoveries to bedside clinical solutions. The objective of this combined Training Program is to build bridges between investigators in basic science departments and physicians in clinical departments, sharing a common goal an in-depth understanding of the development of organ systems. Predoctoral trainees receive their degrees from one of the six Ph.D. granting academic units (the Departments of Biological Sciences, Developmental Biology, Genetics, Molecular and Cellular Physiology, Molecular Pharmacology, and Neurobiology) as well as from the Combined Admissions Mode in the Medical School. Trainees for this component of the Program are selected by the Predoctoral Committee. Postdoctoral trainees have completed a Ph.D., M.D., or equivalent degree and are nominated by a preceptor following a formal application procedure. Candidates for support are evaluated by the Postdoctoral Committee. Post-residency trainees have completed residency training in General Pediatrics and possess the knowledge and skills of a Board-certified general pediatrician. Trainees, therefore, assume increasing clinical responsibilities in the care of critically ill premature and full term neonates. Trainees also choose a research laboratory and preceptor from the Program faculty after selection by the Post-residency Committee. Because of the overlap in research interests among faculty, the trainees have the opportunity to interact with each other and with preceptors within a program representing a wide range of interests in developmental biology, from the most basic to the applied sciences, enhancing the breadth and depth of their training experience.